DeSUMOylation regulation of c-Myc

Project Summary
While properly regulated levels of c-Myc are essential for normal cell growth and proliferation, aberrant
overexpression and activation of c-Myc contribute to most human cancers. Thus, c-Myc level and activity must
be tightly regulated during normal cell homeostasis. The rapid turnover of c-Myc is controlled by ubiquitin-
dependent proteolysis. c-Myc can be ubiquitinated by the Threonine 58 phosphorylation-dependent ubiquitin
ligase (E3) complex SCFFbw7 as well as various other ubiquitin E3s. Conversely, c-Myc ubiquitination can be
reversed by the action of deubiquitinating enzymes (DUBs), including USP28, USP36 and USP37. Interestingly,
c-Myc can also be modified by small ubiquitin-like modifiers (SUMOs). Yet the function of c-Myc SUMOylation
is still unclear and how c-Myc is affected by deSUMOylation is unknown. We recently identified the SUMO
protease SENP1 as a novel c-Myc deSUMOylating enzyme. SENP1 directly binds to and deSUMOylates c-
Myc in cells and in vitro. Overexpression of wild-type (wt) SENP1, but not its catalytic-inactive mutant (C603S),
stabilizes c-Myc and enhances c-Myc transactivation activity. Consistently, knockdown of SENP1 reduces c-
Myc levels and suppresses cell proliferation. We further show that c-Myc can be co-modified by ubiquitin and
SUMO and SENP1-mediated deSUMOylation reduces c-Myc ubiquitination, suggesting that SUMOylation
promotes c-Myc degradation through the ubiquitin-proteasome system. In addition, SENP1 deSUMOylates
USP28 whereas USP28 stabilizes SENP1 and Fbw7 reduces SENP1 levels. Thus, c-Myc levels and activity
may be dynamically controlled by complex ubiquitination-SUMOylation crosstalk. SENP1 is frequently
overexpressed, correlating with the high expression of c-Myc and poor patient survival, in human breast
cancers. Together, these results lead to a novel hypothesis that SENP1 functions as a crucial regulator of c-
Myc by deSUMOylating c-Myc. To gain further insight into the role of SENP1 in regulating c-Myc protein
stability, activity and oncogenicity, we will investigate the molecular and biochemical mechanisms of the
regulation of c-Myc by SENP1 in Aim 1, including how SENP1 contributes to c-Myc stabilization, how c-Myc is
co-modified by SUMO and ubiquitin, and how it interplays with Fbw7 and USP28 to dynamically control c-Myc
turnover. We will elucidate the role of SENP1 in c-Myc-mediated gene regulation in Aim 2 by analyzing
whether SENP1 regulates c-Myc binding and turnover at target gene promoters, whether it regulates specific c-
Myc target gene programs in response to growth signals, and whether SENP1 regulates the spatial localization
of c-Myc in the nucleus. In Aim 3, we will test whether SENP1 potentiates c-Myc-driven transformation and
mammary tumorigenesis, whether inhibiting SENP1 suppresses c-Myc-driven tumorigenesis in vivo, and
whether SENP1 inhibition is efficacious in breast cancer. Achieving these goals will provide critical insight into
how c-Myc is properly regulated by dynamic SUMO modifications, how deregulation of this contributes to
tumorigenesis, and whether SENP1 is a promising therapeutic target in human cancers.

Public health relevance
Project Narrative Aberrant high levels and activity of the c-Myc protein play a key role in cancer formation and progression. This study is to elucidate the molecular and cellular mechanisms underlying the regulation of c-Myc protein levels and activity by the deSUMOylating enzyme SENP1, which could yield important insight into how to target the small ubiquitin-like modifier (SUMO) pathway for cancer therapy.